Role of BCL11B in lineage ambiguous leukemia

PROJECT SUMMARY
Acute leukemias of ambiguous lineage (ALAL) are high-risk leukemia subtypes and include mixed phenotype
acute leukemia (MPAL) and early T cell precursor acute lymphoblastic leukemia (ETP-ALL). These leukemias
commonly express markers associated with both the myeloid and T lymphoid lineages which complicates choice
of therapy. Moreover, the genomic, molecular, and cellular basis of ALAL remains obscure and hinders our ability
to identify more relevant and tailored therapeutic strategies. I recently discovered a new genomic alteration that
is specific to a subset of T/myeloid MPAL and ETP-ALL cases, namely noncoding structural variations that
aberrantly activate the T cell transcription factor gene BCL11B in a non-T lineage cell of origin. Most of these
cases (81%) harbored activating mutations (e.g. internal tandem duplication, ITD) in the FLT3 tyrosine kinase
receptor gene, suggesting functional cooperation between these alterations. This discovery enables faithful
experimental modeling of the earliest stages of ALAL development. My preliminary data demonstrated that
ectopic BCL11B expression is sufficient to drive formation of phenotypic T cells from a pool of extra-thymic
human CD34+ hematopoietic stem and progenitor cells (HSPCs). However, HSPCs are a highly heterogeneous
population of cells with different stemness capacities and degrees of lineage commitment, and it remains
unknown whether a certain subpopulation is most permissive to BCL11B-induced lineage skewing or how
BCL11B transcriptional activity disrupts different HSPC gene regulatory programs to drive the lineage ambiguous
phenotype. The goal of this proposal is to define the mechanisms by which ectopic BCL11B expression
corrupts hematopoietic differentiation to drive development of ALAL. To accomplish this, Aim 1 will use a
single cell in vitro differentiation assay to determine how the developmental state of the cell of origin impacts the
ability of BCL11B/FLT3-ITD to drive lineage skewing. Aim 2 will complement this cell phenotype-based assay
with single cell RNA-seq to identify the spectrum of gene expression changes that accompany changes in
differentiation potential and lineage skewing of different cells of origin. I will also use acute protein degradation
techniques to identify direct BCL11B target genes which will inform on BCL11B-controlled transcription networks
that I will investigate in my future independent research. Collectively, these experiments will clarify the role of
the cell of origin in dictating oncogenic BCL11B activity and identify BCL11B-controlled transcription networks.
In the independent phase (Aim 3), I will investigate the molecular mechanism of BCL11B oncogenic activity to
nominate new therapeutic targets. I will first investigate how BCL11B alters chromatin regulation by identifying
changes in chromatin state and transcription factor occupancy. I will then use a new mouse model to screen for
epigenetic regulators critical for oncogenic BCL11B activity. These aims represent the first steps in elucidating
the cellular and molecular underpinnings of ALAL and will equip me with new knowledge, technical expertise,
and collaborations to establish a research program centered on the gene regulatory control of high-risk leukemia.

Public health relevance
PROJECT NARRATIVE Acute leukemias of ambiguous lineage pose significant clinical challenges due to their unusual “lineage- ambiguous” phenotype that complicates choice of therapy and obscures our understanding of the cellular origins and molecular drivers of this disease. This proposal will build upon my recent discovery that aberrant BCL11B activation is a unique and specific genomic driver of lineage ambiguous leukemia. In this proposal, I will identify how aberrant BCL11B activity disrupts gene regulatory programs of different hematopoietic stem and progenitor cells to alter self-renewal capability and confer a lineage ambiguous phenotype.